Accelerating Discovery by Merging Kinetics with Data Science Methods in Catalytic Organic Reactions

Project Summary/Abstract
Over the past three decades, the Blackmond laboratory has pioneered research in kinetic-assisted
mechanistic analysis of organic catalytic reactions. The data-rich methodology of Reaction Progress
Kinetic Analysis (RPKA), employing in-situ reaction monitoring and kinetic modeling of temporal reaction
proﬁles, has proven to be an innovative tool in organic synthesis and catalysis. Our work has helped to
streamline pharmaceutical reaction process understanding as well as to provide fundamental mechanistic
insights that contribute to catalyst design and development. Looking forward at the future landscape for
research in synthetic organic chemistry, the signiﬁcant potential for data-rich science focuses on artiﬁcial
intelligence and machine learning (AI/ML) methods as an important theme in both academic and
industrial research, fueling the promise of accelerated discovery. The experience and accomplishments
of the Blackmond laboratory positions this group to make signiﬁcant advances over the next ﬁve years in
the study of complex catalytic networks, sometimes referred to as “systems chemistry.” Coupled catalytic
cycles operating together may exhibit emergent behavior that cannot be predicted by a reductive
approach studying single reaction steps in isolation. Key to our proposal is that we offer an approach that
is orthogonal to current data science work in organic synthesis. Most investigations of organic catalytic
reactions extract a single piece of information from each reaction – an endpoint yield or selectivity – which
may be sufﬁcient to characterize simple catalytic cycles; however, structural and electronic molecular
descriptors applied to catalyst systems of higher complexity may by themselves fail to produce accurate
predictive models of the network behavior. To address this challenge, we plan to incorporate dynamic
information about complex reaction networks by incorporating images of kinetic profiles as inputs into
AI/ML models. Capturing this comprehensive temporal information – the “narrative” of an entire reaction
sequence – in AI/ML models may provide mechanistic insights that will uncover and exploit emergent
chemical behavior and aid in the identiﬁcation of new reaction and catalyst combinations.
Two general classes of reaction networks will be developed as proof of concept of this systems-based
approach: i) asymmetric catalytic cascade reaction networks involving sequential catalytic cycles, in
which the products of one cycle become the reactants in the next, much like metabolic cycles in biology;
and ii) synergistic multi-catalyst networks incorporating several catalytic cycles that are
interconnected as cogs in a process, where intrinsic reactivity of each catalyst must be balanced with the
other cycles in the network. We seek to implement predictive designs of novel reaction sequences
by developing kinetics-based markers using the temporal reaction proﬁle as a design tool. A key goal
is to broaden the chemical space accessed by these models.

Public health relevance
Project Narrative An important theme in the future landscape for research in synthetic organic chemistry aimed at drug discovery is the significant potential for data-rich science focusing on artificial intelligence and machine learning (AI/ML) methods in both academic and industrial research, fueling the promise of accelerated discovery of molecules through the development of novel catalytic methods. Our orthogonal approach will expand the information included in such models by incorporating images of kinetic profiles as inputs in the study of complex catalytic networks. Capturing this comprehensive temporal information – the “narrative” of an entire reaction sequence – in AI/ML models may provide mechanistic insights that will uncover and exploit emergent chemical behavior and aid in the identification of new reaction and catalyst combinations for the discovery and development of new pharmaceuticals.